Resolution of telomeric DNA structure barriers by specific structure nucleases

For this fiscal year, we have completed the characterization of a histone variant, macroH2A functioning in telomere maintenance in unique human cancers depends on the alternative lengthening of telomeres (ALT), a homology-directed telomere maintenance pathway. ALT telomeres exhibit a unique chromatin environment and generally lack the nucleosome remodeler ATRX, pointing to an epigenetic basis for ALT. Previously, we have identified a protective role for macroH2A1.2 during homologous recombination (HR) and replication stress (RS). Consistent with an inherent susceptibility to RS, we have identified that ALT telomeres are highly enriched for macroH2A1.2. However, in contrast to ATRX-proficient cells, ALT telomeres transiently lose macroH2A1.2 during acute RS to facilitate DSB formation, a process that is almost completely prevented by ectopic ATRX expression. Telomeric macroH2A1.2 is re-deposited in a DNA damage response-dependent manner to promote HR-associated ALT pathways. Our findings thus identify the dynamic exchange of macroH2A1.2 on chromatin as an epigenetic link between ATRX loss, RS-induced DNA damage response initiation and telomere maintenance via HR. This work is recently published in Nat Struct Mol Biol. 2019 Mar;26(3):213-219. A Fanconi anemia protein SLX4 assembles a complex consisting of endonucleases SLX1, MUS81, and XPF and functions in genome maintenance. Our ongoing projects investigate the mechanism and regulation of the SLX4-nuclease complex in genome maintenance. In collaboration with an extramural laboratory, we have determined the crystal structure of SLX4 in complex with its interacting proteins MUS81 and identified key contacts that mediate the interaction. Specific disruption of these key contacts interrupts SLX4-MUS81 interaction and genome integrity, confirming the necessity of these key residues in the functionality of the SLX4 complex in genome maintenance.